Preclinical validation of an effective oral fulvestrant product as the future standard of care endocrine therapy for ER+ metastatic breast cancer

ABSTRACT
Breast cancer is the most commonly diagnosed form of cancer globally and, when progressed to the metastatic setting,
remains an incurable disease. For the roughly 80% of patients with estrogen receptor positive (ER+) breast cancer,
endocrine therapies (ETs) are effective at limiting tumor proliferation in both the adjuvant (i.e., preventative) and
metastatic settings. However, ETs are susceptible to acquired resistance resulting in disease progression. Progression is
addressed by changing treatment, which is repeated as necessary in order to maximize the duration of response, balanced
by maintaining an acceptable quality of life. Therefore, improving survival of ER+ metastatic breast cancer (mBC) patients
requires the development of new therapies or improvement of existing therapies to increase the potency and/or duration
of each line of treatment. Fulvestrant is a potent and well tolerated selective estrogen receptor degrader (SERD), a type
of ET, used as part of the standard of care, but the clinical efficacy is limited by its poor solubility, which currently requires
administration as a painful monthly intramuscular injection at the maximum feasible dose. The resulting low, steady
exposure yields sub-optimal efficacy and contributes to acquired resistance. To overcome these limitations, VeraMorph
has leveraged its novel “DPOD” oral drug delivery technology to transform fulvestrant into an effective oral treatment
with higher maximum plasma concentrations that simultaneously can improve patient quality of life. Since optimizing the
oral formulation, preclinical studies have shown that oral fulvestrant is well tolerated and significantly improves exposure.
PK studies with oral fulvestrant in rodents achieved maximum plasma concentrations up to 400 ng/mL, roughly 20 times
that achieved clinically by IM fulvestrant, which resulted in 55% more effective tumor growth inhibition than IM
fulvestrant in a cell derived xenograft (CDX) study using MCF7-based tumors. This Fast Track project will expand this proof
of concept in a metastatic and ET-resistant CDX model (Phase I) before progressing into IND-enabling safety studies of the
oral fulvestrant product and the DPOD technology, additional efficacy studies in a patient derived xenograft (PDX) and
immunocompetent mouse model, which all resemble real world conditions, and prepare an IND for clinical translation
(Phase II). The end goal is to commercialize oral fulvestrant as the new standard of care oral ET for ER+ mBC that can also
complement existing ETs in order to prolong patient response and improve survival statistics. Alternative novel oral SERDs
have only shown superiority over IM fulvestrant for patients that have progressed on prior ET and have developed ESR1
mutations, which only account for about 20% of ER+ mBC patients. Thus, for the majority of these patients, oral fulvestrant
provides an opportunity to improve clinical outcomes with minimal risk. Additionally, development of oral fulvestrant will
simultaneously validate the DPOD platform as a safe and effective oral delivery system for poorly soluble drugs, which
account for 9 out of 10 drugs in pharmaceutical pipelines and 4 out of 10 approved products. Therefore, a secondary
outcome of this SBIR Fast Track project will be to enable the development of more effective oral therapies across a broad
swath of diseases currently addressed by poorly soluble drugs.

Public health relevance
NARRATIVE (Public Health Relevance Statement) Metastatic breast cancer (mBC) remains an incurable disease and accounts for roughly 48,000 fatalities annually in the United States. Despite improvements in early diagnosis and numerous treatment options, the 5 year survival rate for mBC remains at only 28%. To improve the survival and quality of life of the roughly 80% of mBC patients with estrogen receptor positive (ER+) disease, VeraMorph has leveraged a proprietary oral drug delivery technology to develop the first ever effective oral formulation of fulvestrant, which is part of the standard of care for ER+ patients. Due to its poor solubility, fulvestrant is only available as a monthly injection with limited exposure. VeraMorph’s oral formulation has been proven to achieve significantly higher levels of exposure and tumor growth inhibition, which can increase efficacy and extend survival. More broadly, development of oral fulvestrant will simultaneously validate the safety and effectiveness of VeraMorph’s oral drug delivery technology, which can enable the roughly 90% of drugs that are also poorly soluble to achieve their full potential as life-saving medications.